Developing a Values Elicitation Tool to Improve Treatment Decision-Making in Acute Myeloid Leukemia

PROJECT SUMMARY/ABSTRACT
This NCI K08 Mentored Career Development Award will prepare Dr. Daniel Richardson to become an
independent R01-level investigator in patient-centered cancer care delivery for patients with acute myeloid
leukemia (AML). AML treatment paradigms are changing for older patients. After almost 40 years without any
new treatments, 10 new therapies have been approved since 2017. These approvals have introduced clinical
equipoise into treatment decision-making for many older patients. Choosing the “best” treatment option often
depends on what each patient values most: optimizing quality of life or prolonging survival. Clinicians and
patients can engage in shared decision-making to clarify patient values and help patients arrive at informed
preferences about therapy. Multiple stakeholders have called for the development of new tools to support
patients and clinicians in this complicated process. Dr. Richardson plans to work under the guidance of his
mentors to evaluate a novel values elicitation tool called “PRIME” (Preference Reporting to Improve
Management and Experience). PRIME generates a personalized values report in real-time to inform shared
decision-making based on best-worst scaling (BWS), a simple yet robust values clarification method. This
proposal builds on Dr. Richardson’s previous research with his mentors to develop values elicitation surveys
for AML patients. The objective of this proposal is to evaluate the feasibility of using PRIME to improve
treatment decisions and optimize its implementation for a RCT to evaluate efficacy. The aims of this study are
(1) to determine the feasibility of using PRIME to improve treatment decision-making and (2) to identify barriers
and facilitators of implementing PRIME into clinical workflows to inform development of appropriate
implementation strategies. Success in this project will advance innovative, rigorous methods to capture patient
values that may have broad applicability across oncology. This project will also promote Dr. Richardson’s long-
term research goal of improving the integration of patient values into treatment decision-making. Dr.
Richardson is supported by a mentorship team with expertise in values elicitation (John Bridges, PhD),
implementation science (Stephanie Wheeler, PhD), and cancer care delivery trials (Ethan Basch, MD, Antonia
Bennett, PhD). As part of this K08 award, he will develop expertise in cancer care delivery trial design and
execution, values elicitation methodology, and implementation science.

Public health relevance
PROJECT NARRATIVE Significant growth in treatment options for patients with acute myeloid leukemia (AML) has increased the importance of understanding patients’ values and preferences to determine appropriate therapy. This project aims to evaluate the feasibility of implementing a novel patient decision support tool to improve treatment decision-making for older adults with AML. This tool uses best-worst scaling, an innovative, yet robust method to elicit patient values, which may be widely applicable to other treatment settings across oncology.